Nemo-like kinase regulation of microglial function and heterogeneity in Alzheimer's disease

PROJECT SUMMARY
Alzheimer’s disease (AD) is pathologically characterized by the accumulation of extracellular amyloid beta (Aβ)
plaques, tau tangles, neuroimmune activation, and synaptotoxicity. Recent immunotherapies have focused on
oligomeric and fibrillar Aβ species to slow or halt symptom progression with limited success, and this remains
an active space for therapeutic development. Activation of microglial phagocytosis presents a promising strategy
to utilize an intrinsic protein quality-control mechanism to counteract the hallmark protein aggregation in AD.
Additionally, a disease-associated microglia (DAM) subpopulation appears in response to AD and several
different neurodegenerative diseases, and accelerating DAM appearance could successfully counteract Aβ
plaque pathology. However, the underlying signaling mechanisms and regulatory checkpoints promoting DAM
activation are still not completely understood. Depletion of Nemo-like kinase (Nlk) in mice is strongly associated
with increased lysosomal and phagocytic activity, but the implications of increasing these pathways in microglia
in an AD context has yet to be examined. Additionally, knockout of Nlk successfully ameliorates both protein
aggregation and behavioral deficits in a murine TDP43-associated proteinopathy model. This Nlk deletion also
induces the expression lysosomal and phagocytic genes that are also upregulated in the homeostatic microglia
to DAM transition. Given this rationale, the central hypothesis of this proposal is that depletion of microglial Nlk
in a murine model of AD will increase phagocytic degradation of Aβ, significantly improve AD phenotypes, and
induce microglia differentiation from a homeostatic state to DAM. Therefore, this proposal aims to measure AD
symptom progression using (1) histopathological markers of disease etiology and (2) behavioral paradigms
assessing cognition and working memory. Biochemical and histological analyses will identify the effect of Nlk
loss on Aβ plaque formation, levels of soluble Aβ oligomers and fibrils, microgliosis, and synapse loss.
Separately, single-cell RNA sequencing (scRNAseq) will assess a conditional Nlk knockout produces
transcriptional changes required for the DAM transition. If the hypothesis is supported, activation of microglia
could present a holistic strategy for counteracting the characteristic protein aggregation in neurodegenerative
proteinopathies. This proposed project will be completed in Dr. Janghoo Lim’s lab in the Yale Departments of
Neuroscience and Department of Genetics. This unique environment will provide the skills and training in both
scRNAseq pipelines and neuro-immune interactions required to successfully complete these aims. The overall
environment at Yale University and within the Yale Interdepartmental Neuroscience Program also provides
opportunities to develop scientific communication and mentoring skills with specific efforts towards diversity,
equity, and inclusion. The proposed fellowship training will prepare the applicant to be a successful independent
researcher studying the role of glia and neuro-immune interactions in the context of neurodegeneration.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is an age-related neurodegenerative disease affecting millions of people worldwide for which limited therapeutics are currently available to slow or halt disease onset or progression. The studies outlined in this proposal will elucidate the role of microglial protein quality control in the context of AD pathogenesis. This will both advance our understanding of the mechanisms underlying the progression of diverse neurodegenerative proteinopathies, and identify potential targets for future therapeutic development.